CRCNS: Heterogeneous effects of cognition on perception: unique leverage on circuit mechanisms

PROJECT SUMMARY (See instructions):
Varying cognitive processes like attention can be a powerful tool for investigating the function and
flexibility of cortical circuits. Attention has dramatic effects on behavior, and deficits in selective attention
are a hallmark of neuropsychiatric disorders ranging from attention deficit hyperactivity disorder to autism
to Alzheimer’s disease. Knowing which of the concomitant changes in the brain are responsible for those
shifts in behavior can reveal what is important about circuit function in the first place.
One of the most notable aspects of how any cognitive process affects cortical circuits is its
heterogeneity: attention has vastly different effects on different neurons, having different magnitude and
often sign effects on the rates and shared variability of even nearby, simultaneously recorded neurons.
This heterogeneity is not unstructured, however. For example, there are neuron-by-neuron correlations
between the magnitude and sign of modulation by spatial attention and by having multiple visual stimuli in
the receptive field, between modulation by feature attention and the strength of a neuron's tuning for the
relevant feature, and between modulation by attention and neuron-behavior relationships.
This structured heterogeneity has the potential to provide unique insight into cortical function because
it could be caused by either network or cellular mechanisms. Through our long running collaboration, the
Cohen and Doiron groups proposed a circuit mechanism that accounts for the effects of attention on
single neurons and on the response variability that is shared within and between neuronal populations.
However, our network model only captures the neuron-averaged correlates of attention.
We will study the role of cell-intrinsic and network properties in the flexibility of circuits in visual cortex.
We will measure, manipulate, and model the activity of large groups of visual and premotor neurons while
modulating multiple types of attention that pose distinct challenges for mechanistic models: spatial
attention (Aim 1) and feature attention (Aims 2 and 3). This ambitious project will combine multi-neuron,
multi-area recordings, causal manipulations, flexible and rigorously controlled behavioral paradigms, and
circuit modeling. Our efforts will produce rich data sets and models that provide a platform for studying
the mechanisms underlying cognition and complex behavior in many systems.

Public health relevance
RELEVANCE (See instructions): Many neuropsychiatric disorders including depression, schizophrenia, autism, and attention disorders involve networks of heterogeneous neurons. We will test mechanistic hypotheses about how populations of neurons guide behavior in different cognitive conditions. Characterizing the complex relationship between cell-intrinsic heterogeneity, network, heterogeneity, and behavior will be critical for diagnosing and developing drug therapies to treat neuropsychiatric disorders.